How HTLV-I Tax and HBZ control telomerase activity to induce adult T-cell leukemia

PROJECT SUMMARY/ABSTRACT The human T-cell leukemia virus type I (HTLV-I) is an onco-retrovirus that infects and transforms human CD4 T cells in vitro and in vivo. HTLV-I is the etiological agent of adult T-cell leukemia/lymphoma (ATLL), an aggressive and invariably fatal hematological disease. The virus is transmitted through sexual contact, contaminated blood and mother-to-child by breastfeeding, and is present in 20-30 million people worldwide. HTLV-I-mediated T-cell transformation arises from a multi-step oncogenic process in which the virus induces chronic T-cell proliferation, resulting in accumulation of genetic defects and deregulated cell growth. It is not yet fully understood how HTLV-I engenders ATLL, but the virus blocks the apoptotic network and expends the proliferative capacity of infected cells. HTLV-I infects and immortalizes primary human T cells in vitro and, after several months, these cells acquire the ability to grow in the absence of interleukin-2, referred to as transformation. We previously demonstrated that the viral oncogenic Tax can reactivate telomerase expression, an event required for long-term proliferation of HTLV-I-transformed cells in vitro and in vivo. This application will investigate the molecular events associated with deregulated telomerase activity and its role in the HTLV-I transformation process. Since telomerase reactivation represents one of the central steps in human carcinogenesis, results from this study will have broad application beyond viral oncogenesis.

Public health relevance
PROJECT NARRATIVE HTLV-I is associated with the development of an aggressive form of lymphocytic leukemia known as adult T- cell leukemia/lymphoma (ATLL). Although many features of HTLV-I biology have been discovered, the disease has no cure. Reactivation of telomerase activity is an essential step in the expansion and survival of HTLV-I- transformed cells in patients. Understanding the mechanisms involved in reactivation of telomerase activity by HTLV-I may uncover novel targets for the treatment of ATLL.